2022 International Conference on HIV Treatment, Pathogenesis, and Prevention Research (INTEREST)

Abstract.
The most recent UNAIDS estimates of the global burden of HIV are that 38 million people are living with HIV-
1 infection worldwide, with 68% of them residing in sub-Saharan Africa. A striking difference exists between the
east/southern and the west/central regions of sub-Saharan Africa, with reductions in AIDS-related deaths since
2010 of 49% and 37%, respectively. Clearly, much work remains in terms of training local physicians and
scientists in the diagnosis, treatment, and management of individuals with HIV-1 infection; conducting
implementation science to determine the most cost-effective use of financial and human resources; and ensuring
evidence-informed public health policy and programming to reduce disparities in the AIDS response across
Africa's sub-regions. Despite treatment likely having contributed to slowing HIV transmission, HIV prevention
remains critical to stem the tide of HIV. In fact, a second AIDS pandemic in the next 12 years is predicted due to
1) changing demographics in Africa with increasing numbers of youth, 2) increasing transmitted viral drug
resistance, and 3) increased cost and limited availability of 2nd and 3rd line treatment regimens. Taken together,
these factors suggest that the total number of people living with AIDS may increase by 2 million/year to reach a
staggering 50 million worldwide by 2030.
Since 2007, 14 successful annual INTEREST Conferences, known as the `African CROI', have brought
together scientists involved in HIV diagnosis and treatment, pathogenesis, and prevention research in resource-
limited settings in Africa to share pivotal findings, promote collaboration, and transfer experiences across several
fields and many continents. Planning and organization of the 2022 INTEREST Conference will be overseen by
the Amsterdam Institute of Global Health and Development. Dr. Kwasi Torpey (University of Ghana School of
Public Health/Amsterdam Institute for Global Health and Development) chairs INTEREST's International
Conference Committee (ICC) and is the new Scientific Chair of INTEREST.
The organizers of the 2022 INTEREST Conference will pursue the following objectives:
1) To provide cutting-edge knowledge in the fields of diagnosis and treatment, pathogenesis and
prevention of HIV-1 for adults, including the elderly, adolescents and children living with HIV in
Africa, in order to contribute to achieving the 95-95-95 viral suppression goal and to preventing a
second great HIV pandemic.
2) To foster new research interactions among leading investigators and those who represent the
potential future scientific leadership for health care and research on the African continent.

Public health relevance
Project Narrative. Currents efforts are ramping up to control local HIV epidemics in Africa by providing effective treatment and prevention strategies for people living with HIV-1 infection. The 2022 INTEREST Conference will focus on the scientific training and capacity building of young African clinicians and scientists whose scope of work is to implement and evaluate evidence-based: 1) early diagnosis and clinical care for HIV-1 infection, 2) effective antiretroviral treatment, and 3) tailored prevention strategies. Moreover, the three-day INTEREST conference, which profiles state-of-the-art science, will support the career development of young African clinicians and scientists by: 1) fostering local and international scientific exchange; 2) providing opportunities to present their results; and 3) facilitating their close interaction with scientific peers and invited international experts to explore career choices and opportunities for scientific collaboration.